Autophagy and Hepatic Stellate cells activation

Project Summary
Liver fibrosis in chronic liver diseases (CLDs) such as viral hepatitis, metabolic dysfunction-associated steatotic
liver disease (MASLD), and metabolic dysfunction-associated steatohepatitis (MASH), is a significant health
problem. The hepatocyte injury during CLDs is followed by replacement of liver parenchyma by fibrotic tissue
with excessive deposition of collagen rich extra-cellular matrix. The activated hepatic stellate cells (HSCs) are
primary source of liver fibrotic tissue. In spite of intensive research, the mechanisms of fibrosis and activation
of HSCs is not completely understood and the development of efficient anti-fibrotic agents remains a priority.
Autophagy, an intracellular degradation pathway, plays an important role in diverse cellular processes in health
and disease. Autophagy has several beneficial effects on the hepatocytes including insulin sensitivity and
degradation of intracellular lipids in the hepatocytes (lipophagy). Autophagy also prevents hepatocyte injuries
including those caused by oxidative stress and inflammatory cytokines.
The role of autophagy in HSCs is, however, ambiguous. Numerous studies depict autophagy as a pro-
fibrogenic process due to its association with HSC activation and liver fibrosis. The main mechanism
underlying autophagy-mediated HSC activation and fibrosis is autophagy-mediated lipid droplet (LD) depletion
which has been shown to concur with HSC activation. On the other hand, several studies show anti-fibrotic
effects of autophagy via promotion of HSC death, degradation of pro-fibrotic mediators including collagen and
metalloproteinases, and inhibition of pro-fibrotic signal carrying exosomes. These discrepancies may be
attributable to the traditionally inefficient and inaccurate autophagy markers, instances of lack of cell-type
specific studies, context of autophagy modulation in relation to the hepatic injury, and the role of autocrine/
paracrine signaling in fibrosis. It is noteworthy that several anti-fibrotic agents including statins are known to
induce autophagy. We hypothesize that precise morphological detection of autophagic process will
clarify the role of autophagy in HSC activation. We will address this hypothesis with the following specific
aims: 1) To morphologically determine the status of autophagy during HSC activation using a novel HaloTag-
LC3 assay; 2) To study the inter-relationship between lipid accumulation and autophagy in the HSC activation;
and 3) To delineate the effect of ROS scavenging on lipophagy and lipid metabolism in HSC fibrogenic
response. By employing the novel HaloTag-LC3 assay which can detect specific autophagy structures and
high parameter metabolic flow cytometry (MetFlow), we will determine the state and role of autophagy in
primary HSCs in the context of HSC activation, HSC-hepatocyte interaction, and lipid metabolic profile. Once
completed, this study will provide a unique knowledge about the specific steps of autophagy involved in HSC
activation and provide a foundation for mechanism-based therapeutic tools against liver fibrosis.

Public health relevance
Narrative Liver fibrosis, as a result of many chronic liver diseases, leads to liver decompensation and liver-related mortality. During liver injury, the hepatic stellate cells (HSCs), also known as perisinusoidal cells, transdifferentiate into proliferative, fibrogenic myoﬁbroblasts which are the primary source of liver fibrosis. The role of autophagy, a highly conserved cell degradation pathway, in HSC activation is ambiguous. We propose to revisit the role of autophagy in HSC activation and fibrogenesis using novel autophagy and metabolic assays.